Flow Cytometry Module

Flow Cytometry Project Summary/Abstract The primary purpose of the Flow Cytometry Module is to provide Principal Investigators with a centralized service for cell phenotyping, sorting (FACS) to obtain viable populations of cells according to specific cellular markers, and biomarker detection. Such a service makes expensive equipment for fluorescent activated cell sorting and analysis available to researchers. In addition, the module helps develop experimental procedures and assists with analysis as well as the interpretation of results. Finally, the module provides full time technical support for the maintenance and calibration of the equipment, a centralized internet access to data and a database for techniques.